An intervention to reduce sedentary behavior for adults with chronic kidney disease: RESET-CKD.

The purpose of this K23 Mentored Patient-Oriented Career Development Award application is to support the applicant’s long-term goal to develop an independent research program focused on improving the health and quality of life for adults with chronic kidney disease (CKD) through healthy lifestyle behaviors. Adults with CKD are extremely sedentary, and the poor health outcomes associated with CKD may be modifiable by addressing sedentary behavior- a lifestyle behavior associated with adverse health consequences. Black adults are disproportionately affected by CKD and have some of the worst health outcomes among those with CKD.
Theory-based behavioral interventions can effectively reduce sedentary time, but research is lacking on theory-based sedentary reducing interventions adapted to meet the unique needs of the at-risk population of adults of with CKD. The overall goal of this award is to adapt an evidenced-based intervention to reduce sedentary time for adults with CKD guided by patient-centered design. During Aim 1, an evidenced-based
sedentary reducing intervention will be adapted to address unique factors that influence sedentary behavior for those with CKD. Adaptation of the intervention will be led by a Patient Advisory Board comprised of Black adults with CKD. In Aim 2, we will conduct a 12-week pilot randomized controlled trial of the adapted intervention (RESET-CKD) to reduce sedentary time for Black adults with CKD. In Aim 3, we will explore the lived experience of the RESET-CKD intervention participants and identify barriers and facilitators to reducing sedentary time. These findings will be used to inform the development of the efficacy trial that will follow this K23 award. Under the guidance of the multidisciplinary mentoring team, the applicant will receive training in clinical trial design and mixed methods to conduct this innovative work and expand the applicant’s program of research. Completion of this proposal will generate data to support an R01 application to conduct a large, randomized controlled intervention to decrease sedentary time and improve outcomes in adults with CKD. This K23 Award will support the candidate’s career development as a nurse scientist by conducting mentored research focused on decreasing sedentary behavior for adults with CKD.

Public health relevance
Sedentary behavior is associated with poor health outcomes and is an extremely common behavior in those with chronic kidney disease (CKD). Black adults are disproportionately affected by CKD and have some of the worst health outcomes among those with CKD. This project will adapt and test an intervention to reduce sedentary behavior for adults with CKD, which will inform the development of a future large-scale trial to reduce sedentary and improve health outcomes for adults with CKD.